IMAGE ANNOTATION FOR NCI CLINICAL RESEARCH DATABASES

The Cancer Imaging Program is hosting anonymized and de-identified image data sets on the Cancer Imaging Archive (TCIA) from select completed NCI’s Clinical Trials Network (NCTN) Phase II and III clinical trials and data collected through the NCI-funded projects such as CPTAC and Cancer Moonshot Biobank, and NCI grant-funded research. The clinical metadata on all these cases along with histopathology images, genomics and proteomic data (CPTAC) will also be made available for researchers via the Cancer Research Data Commons (CRDC). Additional primary data for the datasets are collected and hosted by NCI. These data have been widely leveraged to advance cancer imaging analysis technology and understanding. Increasingly, researchers leverage these data for radiomics and AI analysis which has shown promising potential of increasing the value of these data contribution to cancer detection, diagnosis and treatment workflow.